NeuroDev Kenya: characterizing the epidemiology and etiology of developmental disorders on the Kenyan Coast

Project Summary/Abstract
The NeuroDev Kenya data set will provide an unprecedented opportunity to study the etiology of
neurodevelopmental disorders (NDDs) in East Africa, and create a research resource of international value. It
will be the first large-scale NDD collection in a rural African setting that is deeply phenotyped and genetically
informative, and all data and materials will be made publicly available. In this application, we propose to
conduct extensive analysis of NeuroDev Kenya’s genetic and phenotypic data, beginning in the award’s
second year. The analyses will leverage the rich environment at KEMRI and will be intertwined with our
proposed capacity building activities (Aim 3). Through our capacity building activities, we will provide structured
training in genetics and genetic data analysis, determine whether to introduce a lymphoblastic cell line (LCL)
protocol into NeuroDev Kenya, and determine how to ethically include adults with ID. We will share all data
(e.g. phenotypes, genotypes), and materials (e.g. DNA from blood, possibly LCLs) through the NIH. We will
also share outputs through international consortia and a new African NDD Research Network formalized
through this award (Aim 4).

Public health relevance
Project Narrative There is a severe underrepresentation of African individuals in genetic studies of neurodevelopmental disorders (NDDs), including intellectual disability, autism spectrum disorders, and attention deficit disorder. We propose to address this inequity through the NeuroDev Kenya project, which aims to collect blood and clinical, medical and demographic data from 800 Kenyan children and adults with NDDs, as well as their parents, and age- and ancestry-matched unrelated controls. We will share all data (phenotypic and genetic) and materials (blood DNA) from the study, and integrate the project with extensive capacity building activities. NeuroDev will create a critical foundation for NDD genomics research in Africa.